Phase-1 Healthy adult human safety and pharmacokinetic study of AVR-48, a small molecule macrophage modulator to prevent bronchopulmonary dysplasia in at-risk pre-term infants

ABSTRACT
Bronchopulmonary Dysplasia (BPD) is the most common chronic respiratory disease in infants and is a
devastating condition that disrupts the developmental program of the lung secondary to preterm birth. BPD
affects neonates exposed to mechanical ventilation and, to date, there are no specific drugs available to prevent
or treat this life-threatening condition. The pathologic hallmarks of BPD are hyperoxia-induced pulmonary
inflammation, increased cell death, dysregulated angiogenic factors culminating in impaired alveolarization,
dysregulated vascularization of the lung and pulmonary hypertension. AyuVis Research, Inc, is developing a
novel class of low molecular weight natural oligosaccharide-derived small molecules which activate macrophage
to a non-inflammatory phenotype via TLR4/CD163 signaling. In both mouse and preterm lamb BPD models, the
lead candidate AVR-48 binds to both TLR4 and CD163 resulting in selective activation of the target cell to block
inflammatory mediators in lung and upregulation of endogenous vascularization pathways. The lead compound
AVR-48 enhances production of certain host anti-inflammatory molecule such as IL-10 and growth factor VEGF
with vascularization effects remaining local to lungs, improving lung vascularization/alveolization leading to
improved lung function. AVR-48 also prevents the development of BPD associated pulmonary hypertension.
Importantly, we have assessed the Maximum Tolerated Dose and determined the NOAEL dose of AVR-48 in
adult rats and Dogs and efficacy/safety doses in lamb BPD model via IV dosing, which we will use to determine
the dose ranges of our proposed clinical studies. We have demonstrated all these above-mentioned therapeutic
effects in two BPD models: intraperitoneal injection of AVR-48 prevents hyperoxia-induced BPD in a neonatal
mice pup model at 10mg/kg dose and intravenous injection in invasive mechanical ventilator induced BPD in
pre-term lambs at 3.0 mg/kg dose. In order to advance the lead candidate AVR-48, AyuVis is proposing 1) the
manufacture of GMP quality AVR-48 in sufficient quantities, stability and product packing for use in our clinical
trial, 2) design the clinical protocol and complete the crucial IND and regulatory preparation to support our clinical
planning and 3) perform a Phase 1 SAD/MAD clinical trial using healthy human volunteers.
The completion of this clinical trial will provide the essential safety and pharmacokinetic data required to continue
the product development of AVR-48. The data yielded through the completion of the aims of this project will lead
the way to the development of future clinical project, including a Phase II clinical trial aimed to assess the efficacy
and safety of AVR-48 in preterm patients at risk of developing BPD. Ultimately, our clinical pipeline will bring to
market a prophylactic treatment for BPD, where there is a vastly unmet clinical need.

Public health relevance
NARRATIVE Bronchopulmunary Dysplasia (BPD) is a disease of pre-term infants whose lungs are injured upon exposure to excess oxygen from ventilators, impairing effective gas exchange in the lungs. Ayuvis Research is developing a novel class of immunomodulating compounds derived from chitin that decrease inflammation, improve lung vascularization, decrease pulmonary hypertension and altogether prevent the depelopment of BPD in preclinical large animal model. Our objective in this proposed grant application is to test the safety and pharmacokinetic profile of our lead compound in a Phase I SAD/MAD Clinical Trial in healty human volunteers, which is a key stage in the development of our much needed prophylactic treatment for BPD in infants and treatment for other life-threatening lung conditions.